EFFECT OF PHYSOSTIGMINE ON COGNITION, MOOD AND NEUROENDOCRINE FUNCTIONING

The purpose of the present study is to determine whether physostigmine induces differential effects in healthy males who have been identified as being a high-risk and not at-risk for major depression. The study will compare the effects of physostigmine and neostigmine on cognitive processes, mood state, psychomotor speed, and neuroendocrine functioning in high-risk and non-risk subjects.